Nanoscopic Membrane Modulations Induced by Nanoscale Oligomers

Huntington’s disease (HD) is a devastating neuronal disorder caused by the mutant huntingtin (Htt) protein with
an abnormal expansion of the polyglutamine (polyQ) tract. Mutant Htt has an intrinsic propensity of forming
prefibrillar and fibrillar aggregates. Although aggregates-dictated toxicity has been widely suggested for a
plethora of neuronal disorders, the mechanism of how amyloids cause medium spiny neuronal death in HD
remains unclear. Although fibrillar aggregates are commonly found in plagues and inclusions bodies, small
oligomers are now considered as the dominant molecular toxins underlying many neurodegenerative diseases.
Based on the oligomer hypothesis and the apparent role of membrane assemblies in amyloid toxicity, we
hypothesize that nanoscale oligomers of mutant Htt are responsible for modulating membrane properties,
leading to progressive loss of cellular functions such as unregulated flux of calcium ions and abnormal shape
transformation of synaptic and mitochondrial membranes. We further hypothesize that oligomer-membrane
interactions are lipid specific. Because lipid profile is cell dependent and age dependent, lipid specificity could
serve as a plausible cause for variable cell vulnerability to the same amyloid species. Although polyQ-
membrane interactions have been widely studied, a mixture of prefibrillar and fibrillar aggregates are often
present. Consequently, it is challenging to distinguish which aggregated species is responsible for the
observed effects on membrane properties. We will first separate soluble polyQ oligomers from fibrils and
monomers. We will then use experimental approaches to investigate oligomer-membrane interactions. In Aim
1, we will seek to determine the effects of nanoscale oligomers on microscopic and nanoscopic properties of
lipid membranes. Based on the significance of specific lipids in HD pathogenesis, we will prepare lipid
membranes with defined lipid compositions. Our lipid-dependent studies will elucidate the role of specific lipids
in governing oligomer toxicity. In Aim 2, we will conduct Raman spectroscopy experiments to investigate
atomic-level changes of lipid membranes. Raman spectral data will unveil how oligomers perturb the lipid i)
intra-chain conformational order and ii) inter-chain packing order. A combination of biophysical tools will be
employed in this project, including high-resolution atomic force microscopy (AFM), AFM-based force
spectroscopy, vesicle leakage assay, micropipette aspiration, and Raman spectroscopy. The biophysical
approaches elaborated in this project can to transferred to investigations of an array of oligomers formed by
different amyloidogenic proteins. Therefore, our research will pave the way for future studies aimed at
elucidating molecular bases of oligomer-governed toxicity.
1/1

Public health relevance
Small oligomers are considered as molecular toxins underlying many neurodegenerative diseases. Based on the apparent role of membrane assemblies in amyloid toxicity, we propose to study the impacts of nanoscale oligomers on multilevel membrane properties. Our long-term goal is to understand molecular mechanisms underlying misfolded proteins and neurodegenerative disorders.